Gatlinburg Conference on Research in ID/DD

The Gatlinburg Conference on Research in ID/DD is an annual scientific meeting designed to advance
translational biobehavioral research on intellectual and developmental disabilities (IDD). The meeting provides
a forum for investigators at all career stages to present and discuss cutting-edge biobehavioral research and
theory. The conference focuses on communicating state-of-the-art advances in our understanding of the
causes and consequences of various disorders involving intellectual disability, as well as to reveal new
interventions designed to ameliorate specific disorders. Each year’s conference has a scientific theme that is
explored through plenary lectures, although symposia or poster sessions address a broad range of topics on
IDD from basic to translational and applied science. The themes are designed to expose participants to
theoretical frameworks, methods, and findings from other disciplines and fields of study, including from basic
and translational neuroscience, as well as fields focused on cultural influences on development and IDD.
Historically, the specific aims of the Gatlinburg Conference have been to (a) promote the exchange of scientific
findings, theoretical perspectives, and methodological innovations and thereby accelerate, and encourage
innovation in, translational research on IDD, (b) facilitate collaborative interdisciplinary research on IDD, (c)
ensure that biobehavioral scientists are exposed to relevant translational and basic science findings, methods,
and perspectives from neurobiology and medicine, thereby enriching their research and further supporting
interdisciplinarity, and (d) serve as an interdisciplinary training and career development resource for graduate
students, postdoctoral fellows, and early career faculty. More recently the aims have been modified to include
goals to increase the diversity of the IDD research community by supporting the development of early career
scientists from under-represented groups. These successful aims are largely unchanged from the previously
funded application; however, the current proposal includes several innovations related to communication of
science to nonscientific audiences, and an emphasis on rigor and reproducibility in research, both of which
dovetail well with the conference’s longstanding emphasis on the development of junior scientists.

Public health relevance
Over the last two decades, the field of IDD has become increasingly interdisciplinary, biobehavioral, and translational. The Gatlinburg Conference on Research and Theory in Intellectual and Developmental Disabilities has historically provided a unique venue for the exposition and discussion of the latest biobehavioral research findings, methods, and theoretical frameworks in IDD research. The conference has held a key place in the development of the IDD field. It has launched new interdisciplinary collaborations relevant to IDD, has nurtured and supported the careers of a diverse pool of junior researchers working in IDD, and has been the most critical venue for the bringing constructs and findings from basic science disciplines to the IDD research community. Ultimately, the conference shapes the biobehavioral scientific agenda of the IDD field and accelerates efforts to translate research results into innovative programs of treatment and prevention that will improve the lives of people with IDD and their families.